Supplemental funding for ROTR CHEM 1005 Development of Human Relevant Small Animal Models of Sulfur Mustard Toxicities

The projects under this IAA were developed jointly between the NIAID/NIH (under the CCRP), and the ASPR/BARDA. The funds provided will support supplemental activities directly addressing discovery research and early development of medical countermeasures against chemicals that have identified by the Department of Homeland Security (DHS) as Chemicals of Concern (CoC) targeting the eyes. This IAA will entail development of a preclincal in vivo model of the acute and/or chronic long-term toxic effect of acute CoC poisoning. This IAA will focus specifically on the evaluation of candidate MCMs to mitigate sulfur mustard ocular injury.